Dissemination & Implementation Core

DISSEMINATION AND IMPLEMENTATION CORE PROJECT SUMMARY
Digital therapeutics have demonstrated potential to meet service needs and accelerate translation of science to
practice. The charge of the Dissemination and Implementation (D&I) Core is to provide education, training,
resources, and scientific guidance to advance implementation science and practice for digital therapeutics for
SUDs and CODs. Over the past nine years, the D&I Core has supported activities to promote awareness about
the science of digital therapeutics for SUDs and CODs through traditional and digital dissemination channels
and developed resources to support application of implementation science in digital therapeutic research. Core
affiliates have advanced a conceptual understanding of how implementation science can be applied to digital
therapeutic research and contributed to the knowledge base of facilitators and barriers to implementation of
digital therapeutics for SUDs across a range of populations and settings. In this renewal, the Core will
continue to promote awareness about the science of digital therapeutics (Aim 1) through education,
mentorship, and expansion of the CTBH digital platform features to promote cumulative knowledge about
clinical evidence for digital therapeutics for SUDs and CODs. As new activities, D&I will work with the Center’s
Stakeholder Advisory Board to identify the stakeholder information priorities to inform targeted dissemination
strategies and will add a feature to the CTBH website to advance cumulative knowledge about digital
therapeutic implementation research. The D&I Core will support adoption and implementation of digital
therapeutics (Aim 2) through expanding and refining resources to promote application of implementation
science in digital therapeutic research, including implementation case studies and a common implementation
measurement framework. New in this renewal, the Core will conduct activities to systematically specify
strategies that accelerate implementation of digital therapeutics and offer tutorials to foster actionable skills for
digital therapeutic implementation research. To support new Center priorities, the Core will also engage
affiliates with active later stage digital health projects to include common clinical and implementation metrics to
inform methods for scaling of digital therapeutics, contribute training and methods for use of digital therapeutic
usage data and other digital assessment in studies to elucidate implementation mechanisms of action and
inform adaptive interventions, promote scientific understanding of determinants and strategies associated with
implementation of transdiagnostic digital treatments, provide training and resources in digital health ethics with
regard to access equity and cultural relevance of digital therapeutics, and support training and methods to
increase representation of underrepresented populations in digital therapeutic research. These efforts will
advance the state of implementation science and practice for digital therapeutics for SUDs and CODs.